SYSTEM ADMINISTRATION AND MANAGEMENT SUPPORT FOR BIOMEDICAL AND BIBLIOGRAPHIC INFORMATION RESOURCES

The National Library of Medicine (NLM), in collaboration with the Office of Autoimmune Disease Research (OADR), is spearheading the development of a federated research environment that will significantly advance the integration and analysis of data in autoimmune disease research. This project addresses the inherent challenges in studying autoimmune diseases, which impact a broad spectrum of medical specialties and affect various organs and systems. The complexity of these diseases necessitates a data-driven approach to uncover underlying mechanisms and improve therapeutic strategies.